FEASIBILITY STUDY--VITAMIN D METABOLISM IN EXPERIMENTAL ARTHRITIS

Fractures and bony pain may accompany the arthritis of patients with rheumatoid disease (RA). Bony demineralization has been noted in RA, although the mechanisms responsible for its occurrence are unknown. Evidence suggests that abnormalities in calcium (Ca) homeostasis, leading to hypercalciuria and/or diminished absorption of dietary Ca secondary to reduced levels of 1,25(OH)2D3, the active metabolite of vitamin D, may be responsible. Experimental arthritis may be established in rats by the intradermal tail injection of modified Freund's adjuvant in oil, and is termed adjuvant-induced arthritis (AIA). Similar to RA, bony demineralization also occurs in AIA. AIA will be established in Sherman strain rats, and the hypothesis tested that AIA is associated with abnormalities of Ca homeostasis. External Ca balance will be performed in male and female Sherman rats with and without AIA while the rats are ingesting a Ca sufficient diet, during each of three periods of AIA: the acute onset of arthritis, days 14-20 after adjuvant injection; days 24-30, during which bone demineralization is submaximal: and days 44-50, a time of maximal bone demineralization. Abnormalities of Ca balance at each time point will be related to steady-state measurements of serum levels of 1,25(OH)2D3 and parathyroid hormone and to determination of femoral bone density by single beam photon absorptiometry and to direct histomorphometric evidence of bony demineralization. Additionally, the role of primary hypercalciuria in the abnormalities of AIA induced changes in Ca balance will be assessed by measurement of urinary Ca excretion at the above time points, while the rats are eating a Ca deficient diet. The effect of specific pharmacotherapy (aspirin, hydrocortisone, or D- penicillamine) to relieve the arthritis of AIA will also be evaluated for the effect on Ca balance and bony mineralization during the time periods described above.